Mechanisms of Impaired Granulopoiesis Due to CLPB Mutations

Project Summary/Abstract
The goal of this project is to define the mechanisms by which impaired mitochondrial function leads to
failure of neutrophil development, and how neutrophil precursors use somatic mutations to adapt to this cell-
intrinsic stress. Severe Congenital Neutropenia(SCN) is an inborn disorder of granulopoiesis characterized by
severe chronic neutropenia from birth, premature death secondary to infectious complications, and
transformation to myeloid malignancy. Despite the significant morbidity and mortality associated with SCN, the
mechanisms underlying survival, proliferation, and differentiation of neutrophil precursors remain incompletely
understood. We recently identified heterozygous missense mutations in CLPB as a new and frequent cause of
SCN. CLPB is a nuclear-encoded protein that resides within the mitochondrial intermembrane space where it
functions as a molecular chaperone to disaggregate and facilitate re-folding of misfolded proteins. Our previous
work has also demonstrated impaired mitochondrial oxidative phosphorylation in CLPB-mutant myeloid cells
accompanied by increased cell death. Interestingly, these cells demonstrate an increased non-apoptotic cell
death in response to mitochondria proteostasis stress and sustained activation of the mitochondrial unfolded
protein response (UPRmt). Patients with SCN also develop clonal hematopoiesis that may help alleviate cell
intrinsic or cell extrinsic stress; however, the mechanisms of adaptation to CLPB-mutated SCN are not defined.
In this proposal, we will test the hypothesis that mutant CLPB granulocyte precursors undergo ferroptotic
cell death, a form of non-apoptotic cell death that has been linked to prolonged ROS generation. We will also
test the hypothesis that CLPB-induced mitochondrial stress is ameliorated by RUNX1 mutations leading to a
competitive growth advantage. To this end, the following specific aims are proposed: Aim 1) To understand the
link between sustained UPRmt signaling and cell death in CLPB-mutated granulocyte precursors; Aim 2) To
identify the mechanisms by which RUNX1 mutations promote clonal advantage in CLPB-mutated SCN.
The proposed studies will provide an understanding of the molecular pathophysiology of CLPB-mutant
SCN and RUNX1-mediated clonal adaptation. Ultimately, a better understanding of normal and SCN-related
granulopoiesis may suggest new therapeutic approaches to treat or prevent neutropenia in patients with SCN,
and in patients receiving myeloablative chemotherapy. These studies will also provide critical knowledge on how
mitochondrial stress impacts granulocyte development, and how maladaptive clonal hematopoiesis provides a
growth advantage to these cells. Filling these knowledge gaps can lay the foundation for developing strategies
to augment neutrophil precursor cell survival and differentiation without enhancing risk for malignant
transformation.

Public health relevance
Project Narrative Neutrophils are crucial immune system cells that act as a first line of defense against infections, and an absence of neutrophils places patients at increased risk of death due to uncontrolled infection. We recently identified a new genetic cause for severe congenital neutropenia (SCN), a rare disorder characterized by an inability to generate mature, functional neutrophils. Studying the mechanisms underlying SCN will allow us to make significant advances into basic neutrophil biology, leading to new therapies for SCN patients and patients who have decreased neutrophil numbers in the setting of chemotherapy treatment.